REVIEW AND EVALUATION OF BIOLOGICAL RESPONSE MODIFIERS

Support of the Biological Resources Branch in its function of collecting, reviewing, and compiling available informationon biological response modifiers.